New Statistical Methods for Estimating Health Effects of Environmental Exposures

PROJECT ABSTRACT
This project will develop, test and apply new statistical methods to address analytical challenges associated with
three key research questions in environmental epidemiology: (1) how to utilize exposure data at fine spatial
resolution in health analysis, (2) which individual- and area-level factors render an individual more at-risk to
harmful environmental exposures, and what are the joint health effects of environmental mixture exposures?
We propose methods that adopt state-of-the-art and developing ideas from functional data analysis, Bayesian
analysis and machine learning, while grounding the work on established environmental health study designs,
current analytic practices and real-world data sources. In Aim 1, we will develop Bayesian scalar-on-quantile-
function regression models to estimate associations between aggregated health outcome and population-wide
exposure distribution. This is motivated by the increasing availability of spatially-resolved exposure products.
We will treat exposure quantile function as a functional covariate to better characterize health effect associated
with shifts in different parts of the exposure distribution. In Aim 2, we will extend Bayesian additive regression
trees (BART) models to estimate heterogeneous associations to handle matched case-control data that arise
from the case-crossover design. BART offers a strategy to simultaneously consider multiple effect modifiers
due to its ability to capture nonlinear and complex interactions. We will also develop tools to visualize and
summarize heterogeneous associations. In Aim 3, we will develop Bayesian Gaussian process regression to
estimate joint effects environmental exposure mixtures. We will characterize the exposure-response surface by
providing a more computationally practical and robust framework via random Fourier feature approximation. In
this framework, we will also examine how to perform variable selection/dimension reduction, handle missing data,
and distinguish differences between subgroups. In Aim 4, we will create R packages to handle continuous, binary,
count, and clustered outcomes to facilitate adaptation of these methods by the wider scientific community. Each
methods development area will be paired with motivating and ongoing epidemiologic studies. These include
(1) estimating short-term health effects of wildfire-related air pollution and ambient temperature on emergency
department (ED) visits in multiple U.S. states, (2) identifying heterogeneous effects of temperature on heat-related
ED visits due to individual comorbidity, medication, and residential built environment using electronic health data
from Emory Healthcare, and (3) estimating associations between various environmental exposures and adverse
pregnancy outcomes in deeply phenotyped African-American mother-child dyads and among deliveries at Emory
Healthcare. Overall, this project will provide timely analytic methods motivated by methodological gaps, emerging
data sources and research priorities in environmental health. Our Bayesian approaches to distributional covariate,
tree-based models for matched case-control data, and fast Gaussian process regression may also be appealing
and relevant in other biomedical and public health research areas.

Public health relevance
PROJECT NARRATIVE This project will develop, test and apply new statistical methods to address data analytic challenges in population- based environmental health studies. These methods will help increase the accuracy, reliability and impact of epidemiolgoic studies, as well as advance our understanding of how chemical and non-chemical environmental exposures affect human health.